Pediatric Injury; Modules to Manage Medical Stress

PROJECT SUMMARY / ABSTRACT
Post-traumatic stress symptoms (PTSS) and associated psychological impairment affect from 25 to 57% of
children after an injury and contribute to worse health related quality of life. Because children's PTSS emerge
after they are discharged home from the hospital, they are often invisible to the trauma system and are neither
detected nor treated. Although evidence-based treatment for PTSS exists, limited parental awareness and
access to trained providers hinder community access. The goal of this project is to provide a research and
treatment resource for the management of psychological distress in children who have been hospitalized for a
physical trauma. In Aim 1, we will develop an innovative, brief e-health approach to treatment of PTSS
designed to be delivered through the trauma system. We will create interactive web-based psychoeducational
modules that are developmentally tailored for school age children (8 to 11 years) and youth (12 to 16 years) for
use with synchronous e-health therapy sessions with a trained therapist. Modules will target two evidence
based treatment methods: cognitive behavioral therapy coping skills (coping CBT) and direct exposure to
trauma reminders through a trauma narrative. All modules will be piloted iteratively with parent, child, and
expert practitioner input incorporated at each step. We will develop parent modules that accompany the child
treatment programs that address parent concerns including managing their own stress, parenting skills and
how to help children with a common injury-specific concern, sleep. Treatment resources will be designed
specifically for ease of dissemination and incorporation into the trauma system. In Aim 2, we will perform a
pilot three-armed RCT to examine the feasibility, acceptability and preliminary efficacy of the two brief
treatments (coping CBT and trauma narrative) compared to an untreated comparison group (N = 54). Injured
children and their families will be recruited to participate from the inpatient wards of the three participating sites.
The treatment program will serve as a research resource for a subsequent large clinical trial designed to
confirm efficacy and to examine potential treatment modifiers. To aid in dissemination of this treatment
resource, we will create a webinar that provides training in the use of the manualized therapies and online
modules.

Public health relevance
PROJECT NARRATIVE Children who develop psychological distress after being hospitalized for an injury often have difficulty accessing evidence-based treatment. This project will develop multimedia treatment modules that are tailored to the needs and developmental levels of children ages 8 to 16 years old with post- traumatic psychological distress that can be used on-line with therapist support. Incorporation of online psychological treatment into trauma systems will make treatment more available to children and their families.